Non-Invasive Venous Waveform Analysis (NIVA) in patients with Heart Failure (HF)

Project Summary
Volume overload (congestion) occurs in patients with heart failure (HF) and is the leading cause
of hospitalization in the elderly worldwide. Unfortunately, clinical signs and symptoms;
laboratory values; and existing diagnostic tools are unreliable in providing accurate assessment
of volume status. Using a unique physiologic signal, Non-Invasive Venous waveform Analysis
(NIVA), VoluMetrix has developed a proprietary device and algorithm designed for monitoring
volume status in HF patients. Proof of concept data in humans and experimental animal
models, demonstrate that NIVA provides a reliable indication of intravascular volume status
(“pulmonary capillary wedge equivalent”). The work in this Phase IIB proposal will establish
interface and usability studies to complete the process necessary for bridging the gap to
commercialization.

Public health relevance
Project Narrative Decompensated HF is the leading cause of hospitalization. HF leads to water accumulation in the tissues (lungs and legs) resulting in shortness of breath and leg swelling. This project will advance the development of an accurate, inexpensive, easy to use device (“NIVAHF”) for volume measurements in patients with HF. Use of these devices will ultimately help health care providers and patients prevent water overload. The long-term goal is to prevent costly hospital readmissions, improve quality of life, and reduce mortality in patients with HF.